Dartmouth-Boston University HIV-TB Research Training for the Infectious Disease Institute at Muhimbili University of Health and Allied Sciences

Project Summary/Abstract
The Project Summary of parent award is in the Research Strategy, per the FOA instructions.

Public health relevance
PROJECT NARRATIVE Our Dartmouth- Boston University- Muhimbili (DBM) Fogarty HIV training program will build on our prior Fogarty- supported capacity building activities and train research faculty to conduct HIV and HIV/TB epidemiologic research and clinical trials at the newly established Infectious Disease Institute (IDI) at Muhimbili University of Health and Allied Sciences (MUHAS). We will establish a collaborative mentoring program to ensure junior faculty are supported and successful in performing research and in obtaining independent funding as part of IDI’s research training program while also expanding MUHAS’ portfolio of funded HIV and HIV/TB research. This training program will provide the expertise to establish IDI as the premiere self- sustaining research and training institute for HIV and TB in East Africa.